Administrative Core

PROJECT SUMMARY: Administrative Core
The purpose of the Administrative Core of the Building and InnovatinG: Digital heAlth Technology and Analytics
(BIGDATA) Core Center for Clinical Research (CCCR) is to purposefully focus and prioritize efforts of the center
on the most meritorious and highest impact science within the National Institute of Arthritis and Musculoskeletal
and Skin Diseases (NIAMS) mission. Centered around our main theme of informatics, ‘big data’, and real-world
evidence; the Administrative Core will ensure that the infrastructure and educational needs of our user base of
researchers and trainees are met; and facilitate knowledge translation and dissemination of our user base’s
findings to the research community, patients, clinicians and policy makers. The Administrative Core will work
closely with both the Methods and Health Informatics (MHI) core, with its focus on biostatistics, informatics, and
technology, and a new Dissemination, Implementation, and Community Engagement (DICE) Resource core to
execute on our sub-theme of health equity and community engagement. The Administrative Core Specific Aims
are to: Specific Aim 1: Facilitate the coordination, evolution and expansion of the highly successful MHI Core
and a novel Dissemination, Implementation and Community Engagement (DICE) Resource Core. To ensure
that our users have access to a vigorous intellectual and scholarly research environment, the Admin Core will
coordinate and provide a gateway to our existing and refined services, facilities, applications, and innovative
research projects leveraging the unique strengths of the CCCR investigators and user base using state-of-the-art
tools from rheumatology, informatics, statistics, epidemiology, implementation and dissemination science, and
outcomes research; Specific Aim 2: Oversee the continuation of outstanding educational enrichment programs
designed to bolster the knowledge and skills of the user base to promote high quality clinical and informatics
research and leverage institutional resources such as the National Center for Advancing Translational Sciences
(NCATS)-funded UAB Center for Clinical and Translational Science (CCTS); Specific Aim 3: Foster the
development of Pilot and Feasibility (P&F) project program and provide oversight and management for these
projects; Specific Aim 4: Coordinate interactions between the CCCR Executive, Patient, and Internal and
External Advisory Committees, and existing UAB entities such as the UAB CCTS; and evaluate progress on the
overall strategic agenda of the Center and our three Cores by: a) ensuring goals are met according to key
performance indicators regarding leadership, engagement and the quality of services and resources provided by
BIGDATA to the user base, and b) quantify BIGDATA’s impact on the rheumatologic, musculoskeletal, and skin
disease research community and relevance to our theme and subtheme. BIGDATA’s ultimate goal is to provide
state-of-the-art data capture tools, visualization methods and analytic strategies that can be leveraged by arthritis,
musculoskeletal, and skin disease researchers, with an emphasis on health equity and community engagement.